K SUPPL BP AND GLUCOSE TOLERANCE IN NIDDM PTS. W/HYPERTENSION

Interventional study of the effects of potassium supplementation on BP, glucose metabolism and cellular cation transport in subjects with NIDDM and mid-to-moderate hypertension.